TRAINING NAVIGATOR CCSG SUPPLEMENT

Project Summary
This Administrative Supplement to the Massey Comprehensive Cancer Center’s P30 Cancer Center Support
Grant will support the deployment of two Training Navigators who will identify new emerging and early stage
investigators from underrepresented minority groups in biomedical sciences (pre-doctoral students, post-
doctoral trainees, early stage investigators, and new investigators) who can be navigated and infused into the
National Cancer Institute’s (NCI’s) Continuing Umbrella of Research Experiences program. The Training
Navigators will provide these emerging and early stage investigators step-by-step guidance and mentoring as
well as linkages to research proposal development and other professional preparation and networking
opportunities and services available at Massey, other NCI-designated cancer centers, cancer-related
professional organizations (e.g., AACR), and the NCI. The Training Navigators will build upon Massey’s existing
intra and inter-institutional relationships and concentrate recruiting and mentoring efforts among the eligible
students, trainees, and faculty across three federally designated minority serving institutions – Virginia
Commonwealth University, Virginia State University, and the University of Puerto Rico Comprehensive Cancer
Center in San Juan. The goal of this supplement effort is to identify 12 new underrepresented minority individuals
within one year, approximately four per institution, who will begin and/or continue to actively work and train in
cancer and cancer health disparities research and develop and apply for at least one NCI-sponsored funding
mechanism (disparities supplements, NRSA F or K career development awards, or R21 and other research
project awards). Facilitated by the Training Navigators, these individuals will have access to numerous
informational workshops that will outline the available funding opportunities and best-practice strategies for
developing research and/or career development proposals. The Training Navigators will also ensure that these
emerging and early stage investigators will have convenient access to the rich portfolio of seminars and symposia
led by Massey and other NCI-designated cancer centers and professional organizations on a wide variety of
cancer topics including data science, community engagement in research, and cancer health disparities
research. Finally, the Training Navigators will track and monitor the progress and productivity of these potential
CURE pipeline scholars and report data to the NCI to demonstrate the effectiveness of utilizing specialized
Training Navigators to enhance the next generation of diverse cancer researchers and expand efforts in
addressing cancer disparities through research.

Public health relevance
Project Narrative The goal of this Administrative Supplement to the Massey Comprehensive Cancer Center’s P30 Cancer Center Support Grant is to promote workforce diversity by deploying two highly experienced Training Navigators. These Navigators will focus on identifying and supporting new emerging and early stage investigators from underrepresented minority groups in the field of biomedical sciences, specifically those interested in pursuing careers in cancer research. The Navigators will provide step-by-step guidance and mentoring to these individuals, assisting them in successfully transitioning into their next academic professional career- stages/levels.